Defining genetic and metabolic requirements of aggressive breast cancer

ABSTRACT
While mortality rates for breast cancer (BC) have dropped precipitously over the past few decades due primarily
to advances in treatment and detection, more than 42,000 individuals in the US will still die of this disease in
2019. These BC deaths are largely attributed to recurrent and metastatic disease. While classifiers such as ER
positivity and HER2 status provide insights into BC prognosis and treatment, local and distal BC recurrence
occurs across all BC subtypes. Due to our current inability to predict or prevent BC recurrence, BC is one of the
most overtreated diseases with patients undergoing extended rounds of chemotherapy and treatment that may
provide only marginal benefit. This is especially evident with ER+ (luminal) BCs where long term treatment with
hormonal therapies is recommended for many patients, despite side effects, as a result of our inability to
effectively predict the risk of late recurrence within this group. As such, there is a clear need to better understand
the biology of BC recurrence and to devise a means to treat and/or prevent BC progression. Toward this goal,
we have identified the RON receptor tyrosine kinase and the nuclear DEK oncogene as a signal transduction
axis whose upregulation promotes BC growth and supports BC stem-like cell (BCSC) populations, which are
considered a prime driver of recurrent and metastatic disease. Clinically, RON and DEK are frequently
overexpressed in BC and their combined expression is highly predictive of BC recurrence, distant metastasis
and death in patients across all human BC subtypes. We previously reported that high RON-DEK levels are
strongly associated with β-catenin accumulation in human BC samples and that β-catenin is a synergistically
activated target of RON and DEK. Recent discoveries in our laboratories show that RON or DEK overexpression
increase the levels of key enzymes required for glycolysis, lactate production, and for cholesterol biosynthesis.
We further show that RON and DEK expression increase glycolytic flux consistent with new studies highlighting
metabolic shifts in response to β-catenin activation. Based on this data, we hypothesize that RON-DEK signaling
acts, at least in part, through β-catenin to reprogram metabolic flux for sustaining the energy and macromolecule
synthesis required for BC progression. Thus, the goal of this application is to determine the mechanistic roles of
β-catenin and metabolic reprograming in RON/DEK-driven BC recurrence, and to define and therapeutically
block metabolic effectors of this signaling axis to prevent BC progression and recurrence. Metabolic flux studies
will be carried out in syngeneic animal models of BC and in live human BC specimens. These studies will be
performed by a team of scientists and clinicians, and include a renowned expert in stable isotope resolved
metabolomics approaches, that will be utilized to define RON/DEK dependent anabolic/catabolic processes. This
untargeted approach is expected to identify candidate biomarkers and effectors of aggressive tumors with high
RON/DEK expression. The supposition is that targeting vulnerable nodes of the RON/DEK metabolic signature
will be an efficacious strategy for the treatment of advanced BC phenotypes.

Public health relevance
Narrative. In the United States, breast cancer is the most commonly diagnosed cancer among women and still accounts for over 40,000 deaths each year. The underlying goals of this proposal are to identify, at the molecular level, anti-neoplastic strategies that target breast cancer stem cells/tumor initiating cells and to take advantage of tumor cell selective metabolic processes to ultimately lessen disease related mortality.